Reducing the morbidity and mortality due to acute febrile illnesses in Central America and the Dominican Republic

Abstract
A better understanding of the causes, epidemiology, and risk factors of infectious causes of acute febrile
illnesses (AFI) is a global health priority, particularly for Central America and the Caribbean. AFI syndromes
have overlapping clinical features that make clinical diagnoses challenging and, without advanced laboratory
facilities that rarely are available in Central America, the epidemiology of these pathogens is largely unknown.
In order to ensure that limited public health resources are used efficiently, we need to assure that accurate and
up-to-date data and information are available for targeted and precise interventions. Our innovative project,
Reducing the morbidity and mortality due to acute febrile illnesses in Central America and the Dominican
Republic, will address this information gap on AFIs in the Dominican Republic and Guatemala--two large and
strategically important countries in the Caribbean and Central America, respectively. The specific aims are to:
AIM 1: Determine the risk factors and environmental/sociodemographic drivers of transmission for common
AFI pathogens in the Dominican Republic and Guatemala.
AIM 2: Determine the transmission dynamics and proportionate morbidity serious causes of AFI syndromes in
the Dominican Republic and Guatemala.
AIM 3: Identify emerging and poorly characterized causes of AFI in the Dominican Republic and Guatemala.
For this project, we will conduct two field-activities and three supporting activities: (1) national, population-
representative cross-sectional serological surveys enrolling 6000 healthy children and adults in the Dominican
Republic and Guatemala to detect associations between pathogen serostatus and individuals, environmental
and population-level covariates; (2) prospective sentinel AFI surveillance at two hospitals in each country to
provide data on the morbidity and chronicity of infection of the target pathogens; (3) data analysis and
transmission dynamic modelling using serological and surveillance outputs to characterize risk factors at
different ecological scales, and transmission dynamics and proportionate morbidity of target pathogens; (4)
decision support tools using outputs from the data analysis and modelling to improve the precision of control
interventions; and (5) data sharing and publication of the project outputs.
Study findings and products from this project will allow health ministries to target public health interventions,
thereby increasing effectiveness and assuring limited resources are maximized. The project will also provide
an innovative prototype for how regional and global health authorities can leverage mixed data sources and
novel analytics to achieve Precision Public Health interventions.

Public health relevance
Project narrative This project will provide invaluable data and novel insights into the epidemiology of pathogens that cause acute febrile illness (AFI) syndromes in the Dominican Republic and Guatemala including: (1) detailed investigation of risk factors that operate at different geographical and ecological scales; (2) quantitative description of the core transmission characteristics and epidemiology of a range of serious AFI pathogens, and the application of these measures to inform control intervention; and (3) the presence and importance of a number of emerging and regionally and globally important pathogens. This information and data will be used to develop novel tools and approaches to inform precision public health interventions.